IMPROVED DETECTION OF LARGE BIOMOLECULES IN TOF-MS

One of the most desired improvements in the study of high mass biopolymers in time-of-flight mass spectrometry is increased detector sensitivity and efficiency. The innovations we propose will substantially improve microchannel plates (MCPs) as detectors of high mass biomolecular ions. This will be accomplished through implementation of three separate developments: (1) reducing the MCP surface work function, to increase ion- electron and ion-ion conversion yields leading to improved signal-to-noise ratios (2) enhancing the grazing incidence geometry for incident primary ions through use of a novel square channel geometry, also resulting in increased ion-electron and ion-ion yields: and (3) substantially improving MCP detector dynamic range, which has recently been a limiting factor in analyzing heavier biomolecules in matrix-assisted laser desorption ionization (MALDI). Any one of these improvements would be considered a worthy incremental enhancement in MCP performance. We propose to implement all three simultaneously in the same MCP detector; the result would be a radical departure in the performance of high mass ion detectors. If this is done, MCP detectors will quickly assume the leading role in high mass ion detection in the 50,000 to 1 MegaDalton mass range--just as they are now well established as the leading detectors for low mass ions.